Identifying human neuron IFN-γ dependent anti-Toxoplasma gondii responses

Project Summary:
Toxoplasma gondii is an intracellular parasite that latently infects many hosts, including humans.
Successful latent infection requires T. gondii to evade cytokine-induced, cell intrinsic responses and
switch from a fast-growing form to a slow-growing encysted form. In humans, this life-long infection
occurs in the brain where T. gondii can reactivate in the setting of acquired immune deficiencies. In
AIDS patients, toxoplasmic encephalitis is the most common cause of focal brain lesions and can
cause prolonged neurologic deficits even after appropriate treatment. Recent studies also suggest that,
even in HIV+ patients on effective antiretroviral therapy, persistent T. gondii infection may adversely
affect cognition and global immune responses. Despite its clinical importance, we lack a mechanistic
understanding of what is actually responsible for T. gondii’s pathogenesis in the CNS, including what
enables long-term latent infection. Such understanding is crucial to eventually preventing symptomatic
disease in HIV/AIDs patients. Within the CNS, cysts are primarily found in neurons. Based on limited in
vitro and in vivo studies, it has been presumed that while infected astrocytes cleared intracellular
parasites, neurons did not and thus were the de facto host cell for persistent infection. In the last
decade, our pioneering work has questioned this model, including showing that IFN-γ-stimulated
neurons mount anti-parasitic defenses. As most of this work has occurred in murine models and
neurons, it will have missed human neuron-specific pathways (e.g., humans lack the terminal IFN-γ
dependent proteins used by murine cells to kill intracellular parasites). The goal of this grant is to
address this gap by establishing robust stem cell derived human neuron models (hPSC neurons) which
can be used to mechanistically define human neuron-T. gondii interactions that enable immune evasion
and persistence. To accomplish this goal, our will leverage our synergistic expertise in CNS
toxoplasmosis (Dr. Koshy) and stem cell biology (Dr. Churko) to generate Cre reporter hPSC neurons
and CRISPRi-expressing hPSC neurons (Aim 1) and to begin to define the mechanisms by which
cytokine stimulated hPSC-neurons control T. gondii (Aim 2). With the completion of these aims, we will
have established and validated tools that will form the essential foundation of a long-term program to
molecularly define the neuron-T. gondii interactions that enable control and persistence of T. gondii in
human neurons. The work proposed here represents an important first step toward developing human
neuron-specific therapies for acute and chronic toxoplasmosis. Such therapies will be of great benefit
for the HIV/AIDS population at risk for toxoplasmic encephalitis.

Public health relevance
PROJECT NARRATIVE Toxoplasma gondii is a ubiquitous parasite that chronically infects up to 1/3 of the human population by persistently infecting neurons in the brain. Though asymptomatic in most, this persistence enables the reactivation of T. gondii in patients with acquired immune deficiencies, such as AIDS patients, in whom the infection can be deadly. This work seeks to use stem cell-derived human neurons to develop a molecular understanding of how T. gondii persists in this cell type, ultimately enabling the development of better, curative therapies for those with toxoplasmosis.